Viable Microvessels for the Study of the Microvasculature in Alzheimer's Disease

The brain microvasculature is altered in Alzheimer’s disease (AD), but there are few methods for
studying cellular mechanisms in living tissue. Viable brain microvessels (MV) can be isolated from whole
brain tissue of subjects undergoing rapid autopsy (<12 hours post mortem) in the UW Neuropathology
Core. Recently, this technique has been adapted such that MV in a 3 dimensional (3D) matrix have
extended viability to at least 10 days (d) post-isolation, and scalability to generate numerous replicates for
studies. Subjects are well characterized for the clinical diagnosis of dementia or no dementia, and all
specimens undergo subsequent extensive neuropathologic assessment.
The blood-brain barrier (BBB) of the MV is the interface that regulates movement of substances into
and out of the brain. The principle cellular components of the BBB are brain endothelial cells (BEC),
pericytes, and astrocyte foot processes. Pericytes are closely apposed to BEC and support maintenance
of BBB properties. Importantly, BEC and pericytes contribute to, and are affected by, both the glycocalyx
and basement membrane (BM) extracellular matrix (ECM), which is altered significantly by AD.
Studies of MVs in 3D culture systems allow for spatial analysis of relevant cellular and protein
components. Extended MV viability allows for evaluation of interventions and potential mechanisms that
impact MV health. The goal is to establish these MV to obtain foundational information on microvascular
changes in AD. There are 2 specific aims, with each subject’s MV serving as their own baseline control. In
Aim 1, the hypothesis that MV from age and sex matched subjects, with and without the clinical diagnosis
of dementia, will maintain fidelity (cellular viability, levels of BBB functional proteins, and ECM components)
to their initially isolated MV for prolonged periods (up to 10d) in 3D will be tested. All specimens will have
analysis of their donor en bloc brain specimens, to determine whether MV in 3D will maintain the cellular,
BBB proteins, and ECM phenotype of their brain MV that are examined histologically in situ.
Pericyte loss is accelerated in the MV of brain regions affected by AD neuropathology. A lack of
pericytes is known to result in changes in BBB function, but effects on ECM are not well studied. Aim 2
will determine the effects of pericyte loss on MV derived from brains of subjects without dementia on the
BBB ECM. In Aim 2, the hypothesis that pericyte loss results in alterations in ECM content, such that MV
ECM from those without dementia will resemble MV ECM from those with dementia, will be tested. Aims
1 and 2 will be performed concurrently to optimize utilization of brain specimens. Taken together, data from
these Aims will advance the study of brain MV in AD to create a platform for additional interventional work.

Public health relevance
Viable human brain microvessels (MV) provide a novel opportunity to examine anatomic and functional changes related to Alzheimer’s Disease (AD) and, more importantly, test the effect of interventions that have therapeutic implications. We find that MV freshly isolated from the brains of recently deceased human subjects with and without dementia are viable for up to 10 days in 3D matrix. The goal of this grant is to use these viable MV to determine cellular and biochemical fidelity to their original donor MV and brain tissues, and to define the MV response to pericyte depletion.